Mechanisms involved in postoperative recovery: a focus on pain, delirium, and neuroinflammation

Postoperative recovery in humans varies over a large range and the mechanisms involved are poorly
understood. Peripheral monocytes and brain microglia adopt activation states that can be detrimental to
inflammation resolution pathways involved in postoperative comorbidities like pain and delirium that impact
recovery. The range of activation states correlates to the range of postoperative recovery possibilities observed
in both clinical and experimental settings. This potentially explains the inability of researchers and clinicians to
adequately predetermine a patient’s pain or delirium outcome after surgery, despite extensive basic and
translational studies. The overarching focus of my research program is to identify neuroimmune
mechanisms that contribute to variations in postoperative recovery, such as, pain, cognition, and
depression, accounting for age and sex. Our approach will combine innovative technologies and
relevant pre-clinical experimental models to investigate monocyte/microglia involvement in
postoperative recovery with a focus on pain and delirium. In the past 5 years, we have begun to elucidate
how age and sex influences neuroinflammatory processes involved in pain and cognitive deficits to inflammatory
stimuli, a condition like surgery. We and others have determined that changes in pain and cognitive states in age
is related to “priming” of the immune system and not “current” conditions. Building from our current work, over
the next five years we propose to: 1) Build a clinically relevant postoperative assessment system to evaluate
recovery phases in the context of pain and delirium in rodents. Initial experiments to assess weight loss, body
temperature, and ambulatory movement in male and female young and advanced age groups will set an
important premise. 2) Determine how age and sex influence monocytes (pain) and microglia (delirium) to
modulate neuronal processing is an imperative step toward therapeutic development. We will apply the genomics
method of “translating ribosome affinity purification”, (TRAP) to peripheral monocytes and brain microglia. A
major strength of TRAP is the ability to identify a cell-specific “functional transcriptome”. This approach utilizes
transgenic mice and captures actively translating mRNAs located on ribosomes during protein synthesis. This
allows for quantification of translated RNAs using sequencing techniques. An important point of innovation and
impact for our proposed work is that the identity of functional mRNAs in immune cells in aging, sex, and surgery
will be revealed. Of most interest will be regulation of inflammatory cytokines known to promote pain and/or
delirium after surgery. The work proposed is highly innovative because it integrates advanced methods to resolve
our understanding of postoperative pain and delirium, to eventually move these molecular insights toward new
therapeutic strategies, which aligns with the growing emphasis on human molecular neuroscience in my home
department and research center. Our vision is to integrate behavioral and quantitative, cell-type specific
transcriptomics to create intuitive descriptions of the diverse recovery outcomes observed postoperatively.

Public health relevance
PROJECT NARRATIVE/PUBLIC HEALTH RELEVANCE: Postoperative pain and delirium are factors that complicate recovery and impose a substantial healthcare financial burden (~$60B/year). The overarching goal of this project is to identify key molecular pathways that underlie diverse neuroinflammatory processes involved in pain and delirium, to help reveal treatable targets.